Mechanisms of cell-autonomous plasma membrane stabilization and repair in plants

Project Summary
The long-term goal of this project is to characterize molecular mechanisms governing plasma membrane
stabilization and repair in plants. Despite extensive studies in animal systems, cell-autonomous plasma
membrane repair (CAPMR) in plants is an uncharted territory. This is most likely due to the fact that all plant
cells (except gametes) contain a rigid cell wall that makes precise and reliable plasma membrane wounding
and study very difficult. Our recent genetic studies show that knocking out three Mildew Locus O (MLO) genes
MLO2, MLO6 and MLO12 in an immuno-compromised Arabidopsis mutant background results in “complete
immunity” against obligate biotrophic fungal pathogens causing powdery mildew diseases. Further examination
of such mutant lines revealed no signs of defense activation, indicating that these three MLO proteins serve as
bona fide host susceptibility factors of powdery mildew fungi. This raises a critical question: what is the cellular
function of MLO2, MLO6 and MLO12 that is co-opted by powdery mildew fungi for pathogenesis? It is known
that MLO2-GFP is targeted to the fungal penetration site where the fungal feeding structure—the haustorium—
is initiated. Interestingly, MLO2-GFP also exhibits focal accumulation in the sites of plasma membrane damage
induced by a sharp needle. Based on these observations, it can be hypothesized that (i) MLO2, along with
MLO6 and MLO12, participates in CAPMR in leaf epidermal cells and as such (ii) powdery mildew fungi
co-opt this host mechanism to seal the host-fungal membranous boundary for haustorial
differentiation. To test this hypothesis, higher-order mlo mutants will be created in different backgrounds and
evaluated in comparison with their respective parental lines after treatments that induce membrane damages.
If MLOs are indeed required for CAPMR, proximity labeling will be used to identify potential MLO2-interacting
proteins. Meanwhile, multiplexed CRISPR mutagenesis-based reverse genetics will also be used to circumvent
functional redundancy and identify new components that participate in MLO-dependent CAPMR. Selected
genes or gene families for CRISPR mutagenesis include genes encoding glutamate receptors (GLRs),
calmodulins, SNAREs and synaptotagmins, as well as additional MLO family members. The genetically
identified new components will then be further evaluated for their subcellular localization and interaction with
MLO2 in powdery mildew-infected cells and uninfected cells. More detailed molecular characterization will be
conducted for those that play essential roles in CAPMR in plants. Information from this project will likely fill an
important knowledge gap in CAPMR in plants, inspire new strategies for creating more stress-resilient plants
and provide novel mechanistic insights into similar processes in animals.

Public health relevance
Project Narrative Cell-autonomous plasma membrane repair (CAPMR) is a fundamental and intricate cellular process across eukaryotic organisms, yet its characterization in plants has been limited due to the presence of rigid cell walls. Genetic evidence supports a critical role of Mildew Locus O (MLO) proteins in this process in Arabidopsis. Leveraging MLO2's focal accumulation at fungal penetration sites and its facilitation of host entry by an invading obligate biotrophic fungus as dual indicators, we aim to identify and characterize MLOs and additional proteins involved in calcium signaling, vesicle trafficking, and membrane fusion essential for CAPMR in plants.